How to build a gliding mammal: Using natural phenotypic variation to define the molecular regulation of tissue morphogenesis

Genomic changes that modify developmental gene regulatory networks (GRNs) underpin both natural
phenotypic variation and inherited disease states. Thus, studying natural diversity can provide profound
insights into human development and the etiology of various disorders. However, most of our knowledge
presently comes from a small number of traditional model species that do represent the diversity of mammalian
developmental programs. Therefore, I seek to unravel the mechanisms underlying convergent evolution of
major phenotypic innovations as a way to discover uncharacterized developmental programs shared among
mammals. Here, I propose to define the developmental regulation of the gliding membrane or patagium, a
specialized skin structure connecting the fore and hindlimbs that allows unpowered flight. Notably, the
patagium has arisen independently six times among disparate mammal lineages. Because of its remarkable
convergence, I hypothesize that the patagium may reflect GRNs that are shared among all mammals. Thus,
the research I propose will uncover highly generalizable principles about mammalian development and will
significantly expand our understanding of how conserved GRNs are re-deployed to generate phenotypic
novelty. My proposal consists of three aims that together present an exciting roadmap to address this
fundamental question. In Aim 1, I will profile the transcriptional landscape of the patagium in the sugar glider
(Petaurus breviceps) and compare it to that of adjacent skin and to lateral skin in a non-gliding marsupial, the
fat-tailed dunnart (Sminthopsis crassicaudata) and in the laboratory mouse. I will use gene network analyses to
identify regulatory modules with patagium-specific activities and within them, genes that are differentially
expressed in the patagium. In Aim 2, I will define intramodular regulatory relationships using an upregulation-
qPCR screen. I will then test the necessity and sufficiency of identified regulatory genes to drive patagium
phenotypes through in vivo experiments in the glider, dunnart and mouse. This comparative approach will
allow me to distinguish conserved mammalian developmental programs from novel programs in gliders. In
parallel with Aims 1 and 2, I will define the cis-regulatory circuitry controlling patagium gene expression in Aim
3. I will use epigenomic profiling to locate active enhancers of patagium genes and analysis of evolutionary
rates to identify enhancers evolving adaptively in gliders. The loci that emerge from these independent, but
complementary approaches will then be functionally investigated using STARR-Seq. Uncovering
developmental program of the patagium will provide a framework for how gene regulatory information is
translated into morphological outputs and how conserved developmental programs are re-deployed to drive
novel phenotypes. Under the supervision of my co-sponsors, I will accomplish three major training objectives:
1) gaining experience in functional genomics, 2) learning techniques in molecular and developmental biology
and 3) building career skills that will be necessary as I move toward greater independence as a researcher.

Public health relevance
Project Narrative Defining the mechanisms that relate genotypic changes with their phenotypic outcomes is essential for understanding human development, unraveling the etiology of inherited disease and translating the findings of the genomics era into improved outcomes in human health. Here, I propose to define the gene regulatory networks and cis-regulatory circuitry underlying formation of the patagium, a novel skin structure in gliding mammals. Unravelling the developmental program of the patagium will provide a framework for how gene regulatory information is translated into morphological outputs and how conserved developmental programs are re-deployed to generate novel phenotypes.